Microglia antigen presentation in the CNS of Alzheimer's disease

Project Summary/Abstract
Alzheimer’s disease (AD) is an age-related neurodegenerative disease characterized by progressive cognitive
decline and dementia. Genome-wide association studies have identified novel AD susceptibility loci.
Interestingly the associated genes at several of these loci implicate the immune system in late-onset AD
(LOAD), specifically the innate immune system, including the human leukocyte antigen (HLA) region. The
finding of the HLA region being genetically associated with LOAD further emphasizes the question of how
microglia, the antigen-presenting cells of the central nervous system (CNS), interact with infiltrating T cells,
which have been observed in the hippocampus of AD patients, and specifically what antigens are
being presented. In parallel, the pathogen hypothesis has garnered more support for a possible pathogenic
etiology of AD. We propose to leverage our understanding of the immune system combined with
cutting-edge technology and access to AD patient blood and brain autopsies to determine if these
neuroinvasive pathogens are neurovirulent in AD. For this application, we propose a multifaceted approach
to: 1) identify the peptides being presented by the MHC of microglia in the AD brain in regions of high T cell
infiltration and areas of low T cell infiltration; 2) examine the antigen reactivity and phenotype of T cells
infiltrating the hippocampus in AD, and 3) determine how microglia function as antigen-presenting cells of
pathogens to infiltrating T cells.

Public health relevance
Project Narrative Relevance to public health. This project is of direct relevance to Alzheimer’s disease, as we are studying isolated immune populations from the CNS of individuals with Alzheimer’s disease. We will be examining the phenotype, antigens being presented and antigen reactivity of individual single-immune cells. We will be examining the interaction of the pathogen hypothesis and the CNS immune cells in the human system.